UJMT - NIEHS - Baldewsingh

ABSTRACT
Since its inception in 2012, the UJMT Fogarty Global Health Fellows Program—led by the University of North
Carolina at Chapel Hill, Johns Hopkins University, Morehouse School of Medicine, and Tulane University—has
provided a critical pathway to global health research careers. Our 252 trainees have collectively secured $88.5
million in grant funding, a nearly 600% return on the NIH’s investment. During the current grant cycle (2017-
present), our 110 doctoral scholars and postdoctoral fellows have published a collective 287 manuscripts,
including 109 as primary author. The vast majority remain involved in global health research and many have
already obtained independent grant funding. In the coming grant cycle (2022-2027), under the new LAUNCH
initiative, we build upon these strengths to further improve and expand our program. First, we will provide
enriching 12-month mentored training opportunities at affiliated research sites in 16 countries. We draw upon a
talented pool of US and international candidates, jointly recruited from 12 domestic and 17 international training
programs funded by the NIH. Our expert mentors support experiential learning on site, while the program
provides a central training framework that monitors progress through individual development plans, core skills
checklists, and regular group check-ins. Over the course of the five-year award, we expect to support at least 60
positions via base funding; in line with the RFA, 60% will be US postdoctoral fellows. Second, we will continue
to foster research in scientific areas identified by in-country stakeholders. This includes topics described in the
RFA (e.g., HIV/AIDS, non-communicable diseases, cancers, mental health, neurologic disorders), as well as
other longstanding priorities within our host countries (e.g., infectious diseases, women’s health, child health,
environmental health). Third, we will enhance our training curriculum. We have developed a new Research
Leadership Academy for Global Health, building upon our team’s experience in global health and leadership,
institutional resources, and collaborations with other US government programs. We also provide individually
guided research methodology training and scientific writing support, using proven approaches. Fourth, we will
increase the participation of underrepresented groups in global health research, by identifying and addressing
barriers, emphasizing diversity in recruitment efforts, fostering diversity during the fellowship year, and
supporting a pipeline of future candidates. Fifth, we will monitor, evaluate, and learn from our activities to
iteratively improve the quality of our trainee experience. We utilize a conceptual framework that considers both
process and performance to ensure that the specific aims of the program are met. Finally, the UJMT LAUNCH
initiative will be led by a team of committed global health researchers—and a broad network of engaged
collaborators, both in the US and abroad—with the expertise and experience to carry out its ambitious aims.
Through this program, we will train a diverse group of productive, independently funded, research leaders who
are prepared to tackle the most pressing global health issues in the years to come.

Public health relevance
NARRATIVE This program builds upon the highly successful UJMT Fogarty Global Health Fellowship, now in its tenth year. Its cornerstone is a 12-month, mentored research training opportunity at one of 30 institutions across Africa, Asia, and the Americas. We further strengthen the program with an innovative curriculum on research leadership, new approaches to enhance diversity in global health, and research platforms aligned with regional and international scientific priorities.